Prospective memory impairment in Parkinson disease-related cognitive decline: Intervention and mechanisms

PROJECT SUMMARY/ABSTRACT:
Parkinson disease dementia (PDD) – one of the Alzheimer's Disease Related Dementias (ADRD) – is
associated with increased disability, mortality and healthcare costs among people with PD. The long term goal
of this research is to reduce disability and delay the onset of the ADRD PDD by enabling people at risk for
PDD to cope with cognitive decline to maintain daily function. Existing medical treatments for PD do not
prevent or treat cognitive impairment, so behavioral interventions that mitigate its negative functional
consequences and potentially delay or slow PDD are a top research priority. Unfortunately, the widely-used
process training approach to cognitive intervention (repetitive practice of tasks designed to challenge and
improve particular cognitive functions) has been unsuccessful in improving daily function and quality of life in
this population. To overcome this limitation, the investigators take a strategy training approach, teaching
targeted strategies that people can use in their everyday lives to circumvent cognitive deficits and accomplish
daily tasks. Strategy training is a practice standard for cognitive rehabilitation in brain injury and stroke, but its
application to PDD is novel. Moreover, the strategy training intervention developed for this study explicitly
focuses on generalization of training to daily function, an aspect that is critically lacking from many typical
strategy training approaches and from PD-related cognitive intervention research to date. This project
addresses prospective memory, or the ability to remember to execute delayed intentions at the appropriate
moment in the future. Good prospective memory is essential for independent living, employment, social
relationships, and compliance with important health behaviors. People at risk for PDD have prospective
memory deficits that relate to worse daily function and quality of life. Therefore, prospective memory
impairment is a relevant cognitive problem to address in this population. The primary objective of the current
project is to determine the efficacy of mechanistically-targeted strategy training on prospective memory among
people at risk for PDD (PD with subjective cognitive decline). It is a single-blind randomized controlled trial
comparing the effects of strategy training to the traditional process training approach on objective laboratory
prospective memory performance (Aim 1) and reported everyday prospective memory function (Aim 2).
Additional objectives are to investigate neural mechanisms of prospective memory impairment in PD (Aim 3)
and neural and behavioral predictors of prospective memory training response (Aim 4). This project leverages
participants, data and infrastructure from an existing longitudinal cohort of PD and control participants to
evaluate short-term and long-term training effects, neurobiological mechanisms, and predictors of treatment
response. This work will meet the pressing need for effective cognitive interventions that delay functional
impairment associated with PDD and will positively impact function and quality of life in this population.

Public health relevance
PROJECT NARRATIVE Cognitive decline in Parkinson disease (PD) causes disability and reduced quality of life. Current medical treatments do not prevent or treat cognitive decline in PD, so behavioral interventions that mitigate its negative functional consequences and thus potentially delay the onset of dementia are in high demand. This study will test the efficacy of a targeted training approach for improving cognition and daily function in people with PD and may ultimately result in enhanced independence and quality of life for this population.